Developing intrabody therapeutics for mitochondrial DNA heteroplasmy

PROJECT SUMMARY
Numerous diseases arise from the presence of both normal and pathogenic mutant forms of mitochondrial DNA
(mtDNA). A modest reduction of this heteroplasmy in favor of the normal mtDNA can lead to significant patient
benefit. We intend to identify single-chain antibodies (scFvs) that recognize structures unique to some
pathogenic mtDNA sequences. Because scFvs can inhibit polymerases, we seek to identify novel antibodies
that block replication of particular pathological mtDNA variants that cause primary mitochondrial disorders. ScFvs
have been identified that recognize the general family of DNA structures being targeted, called G-quadruplexes
(G4s). Using positive and negative phage screening, we will isolate scFvs with the ability to bind a specific G4
structure. We will characterize scFvs in biophysical and biochemical experiments to identify lead candidates that
discriminate between pathogenic and normal mtDNA structures. Lead scFvs will then be functionalized with
mitochondrial-targeting sequences for targeted expression in mitochondria to test for beneficial heteroplasmy
shift. ScFvs that exhibit the highest affinity and most potent blockage of polymerase activity at the target
sequence will then be studied in cell culture, where cell uptake, localization, and phenotypic effects on
heteroplasmy and mitochondrial oxygen consumption will be determined. The advantages of this mt-scFv
expression approach are that it is selective, easily targeted to mitochondria, and can be repeated to maintain the
achieved health benefit.

Public health relevance
PROJECT NARRATIVE Mitochondrial genome (mtDNA) mutations cause a range of disorders that frequently manifest in early childhood to cause a life-long care burden with high mortality. For patients affected by a mtDNA mutation, there is no effective therapy or cure. We propose to identify antibodies from a library that recognize a unique structure formed exclusively in one specific mtDNA mutation and direct that protein to the mitochondria to selectively inhibit replication of mutant mtDNA, allowing normal mtDNA levels to increase. Because a subtle increase in the ratio of normal to mutant mtDNA can have significant clinical benefits, our proposed approach not only promises to provide a valuable method for studying mtDNA biology but also has great potential for translation into patient treatments.